Actin Nucleation by Integrin Complexes

DESCRIPTION (provided by applicant): This application is intended to provide additional training and protected time for the principal investigator to develop a new area of research in parallel to current NIAID funded research. Our efforts to describe the activation of hematopoietic integrin receptor activation has progressed rapidly and, along with other recent reports, now suggests that activated beta-3 integrin complexes orchestrate the assembly of actin into stress fibers. This novel hypothesis requires the use of a recently developed in vitro assay of actin assembly and the application of advanced two-color live digital microscopy. Formal advanced training in fluorescent microscopy and significant investigator time will be required for the completion of these experiments. The addition of live cell imaging and fluorescent microscopy will be necessary to appropriately continue the investigators long-term study of hematopoietic cell integrin-mediated adhesion and motility. Current theory of cell motility and adhesion proposes localized actin assembly leading to membrane deformation. This would be followed by integrin interaction first with matrix ligand and then with cytosolic F-actin. Recently, actin nucleating proteins were shown to associate with integrin complexes. We have developed an in vitro assay for actin assembly by purified hematopoietic integrins. This assay reflects deficiencies in cell adhesion through quantitative and qualitative assessment of actin polymerization and was developed to investigate the failure of a Tyr747Phe mutant β3 integrin to support cell adhesion. Current NIAID funding supports continuing investigation into the signaling mechanisms and physiologic relevance of β3 tyrosine phosphorylation, but does not provide support for determining integrin control of cytoskeletal assembly. We hypothesize that integrin activation sequesters actin nucleating proteins and that the activated integrin complex serves as the origin of actin fiber assembly during stress fiber formation. If true, this will join integrin signaling and actin assembly fields in a unique approach to understanding cell adhesion and motility. Utilizing integrins purified from hemaotpoietic cells, that exhibit an inactive basal state and applying technology from the actin biochemistry field we will establish in vitro actin stress fiber assembly as an integrin function and use it to understand integrin regulation of cell adhesion and motility.